Retinoic acid-dependent mechanisms patterning the cardiac progenitor fields

Project Summary/Abstract
Congenital heart defects (CHDs) are the most common type of birth defects, occurring in 1% of newborns. CHDs
can lead to infant illness, mortality and can pose a higher risk for cardiovascular complication in adults, even
after corrective surgery. Despite their high prevalence, the molecular etiology underlying CHDs are not well
understood. To develop targeted therapies for patients with CHDs, it is crucial to understand the fundamental
mechanisms that direct cardiac progenitors into the specific heart fields. Our long-term goal is to understand the
conserved mechanisms that regulate normal heart development. Early differentiating cardiac progenitors within
the anterior lateral plate mesoderm (ALPM) give rise to the first heart field (FHF), while later differentiating
progenitors comprise the second heart field (SHF). It is known that retinoic acid (RA) signaling in vivo restricts
the cardiac progenitor fields within the ALPM by indirectly repressing FGF signaling during developmental
patterning of the embryonic anterior-posterior axis. Studies in mice have indicated that Six transcription factors
(TFs) interact with TBX1 to regulate FGF8 signaling during mammalian cardiovascular development. The
mechanism by which RA regulates specification of the FHF and SHF within the ALPM is not understood. The
specific aims of this proposal are to elucidate the molecular mechanisms by which RA regulates FHF
specification through an early tbx1-six2a-Fgf signaling cascade. Tight RA regulation is critical for vertebrate heart
development and Six TFs are evolutionarily conserved among vertebrates, with zebrafish Six2a being
homologous to mammalian Six2. Interestingly, our preliminary studies in zebrafish indicate that a deficiency in
RA predominantly leads to an increase in FHF progenitors cells within the ALPM. Our Bulk RNA-seq analysis of
early stage zebrafish embryos revealed an upregulation of six2a in RA-deficient conditions and suggest an earlier
requirement for Six TFs in heart development than previously thought. Overexpression of six2a results in
anteriorization and larger zebrafish embryo heads, similar to what is observed in the RA-depleted mutants.
However, we currently have no understanding of the signaling network functioning downstream of RA signaling
to regulate the specification of FHF progenitors within the ALPM. In Aim 1, we will use novel six2a-reporter
transgenic lines and six2a mutants to determine if excess Six2a contributes to the enlarged FHF progenitor
population in RA signaling deficient embryos. In Aim 2, we will perform genetic epistasis experiments to
determine if Six2a functions within a Tbx1-FGF signaling network downstream of RA signaling to limit CM
progenitor specification within the ALPM. Due to the role of RA in vertebrate heart development and the
conservation of Six TFs, these studies will greatly improve our understanding on how disruption in the pathways
that control the differentiation of cardiac progenitor populations can lead to CHDs in humans. As a result, these
studies will allow for the development of better therapeutics to treat CHDs in children as well as adults with
cardiovascular complications resulting from CHDs.

Public health relevance
Project Narrative Despite being the most common form of birth defects, we do not fully understand the mechanisms underlying congenital heart defects. The proposed studies will provide greater knowledge behind the fundamental development of the vertebrate heart and the causes that give rise to congenital heart defects. The information gained from this project will aid in the development of more targeted therapeutics to treat children with congenital heart defects and help in the treatment of adults with cardiovascular complications.